TOPIC #411 - PHASE I SBIR CONTRACT - AN IMAGEDX BASED PLATFORM FOR COMPREHENSIVE DE-IDENTIFICATION OF WSI DATA

The objective of this proposal is to develop a de-identification tool capable of ensuring adherence of whole slide imaging (WSI) data from multiple vendors to the HIPAA Privacy Rule. Such a de-identification tool will be used to more efficiently and comprehensively de-identify the large data stores required by commercial and government funded researchers. Deidentification will be developed as the ImageDx De-ID module, extending the current Reveal Biosciences portfolio of commercial ImageDx modules providing comprehensive computation pathology services. The following Aims will be completed using our Design Driven Development process: (1) Landscape analysis ? to identify vendors, filetypes, and PHI fields; (2) Identify and provide data sets ? datasets provided from existing de-identified slides, slide labelers, and inhouse scanners; (3) Recognize, open, display, and alter WSI files ? develop proof of concept De-ID interface capable of opening and altering PHI information in WSI files across multiple vendors; and (3) Identify data sets and file types for Phase II. The end of project deliverable is an ImageDx De-ID module capable of recognizing, opening, displaying, and altering PHI fields from multiple WSI scanner vendors.